Data and Statistics Core

Core Summary/Abstract
The Data & Statistics Core will fulfill an essential need to ensure that the ASPiRE (Advancing Science and
Practice in the Retail Environment) Center will achieve its mission to build evidence supporting innovative
tobacco control approaches in communities. Critical for carrying out the aims specified by the three projects is
the access to curated, integrated, and analyzable data as well as support for study design and data analysis of
big and complex data. For example, investigators require access to data on 43,000 retailers in the big cities
and 11,539 census tracks and school boundary shape files over time. The specific goals of the Core are
therefore to curate and manage geospatial data for characterizing change over time in the built environment for
tobacco in the US and 30 Big Cities; to integrate primary and secondary data sources that are shared by
research teams across the ASPiRE Center; and to provide geographic information systems (GIS) support and
statistical guidance to enhance the research and dissemination aims of the ASPiRE Center. To meet its goals,
the Core will employ open-source secure web-based tools such as RECap for housing and integrating shared
data, statistical techniques appropriate for the analysis of big and complex geospatial data such as lag
regression and generalized linear mixed effects models, and expertise in GIS programming. The Core includes
a stellar team with extensive experience in innovative study design, longitudinal modeling, informatics and data
integration, geospatial modeling, and programming in GIS software. Importantly, the operation of the Core will
rely heavily on the philosophy that Core members should be fully integrated into the research teams of the
respective projects as well as in the infrastructural support in order to optimally meet the projects’ data-related
needs. To that end, each project as well as the Dissemination & Implementation Core is represented by three
key members of the Core. By addressing its aims, the Data & Statistics Core will ensure the success of the
scientific goals for ASPiRE by establishing shared data sources for the Research Projects, providing specific
expertise on geospatial modeling, designing studies, implementing analyses, and providing principal
interpretation for dissemination.

Public health relevance
Core Narrative/Public Health Relevance Critical for achieving the public health mission of the ASPiRE (Advancing Science and Practice in the Retail Environment) Center is the access to curated, integrated, and analyzable data as well as support for study design and data analysis of big and complex data. The Data & Statistics Core will meet these essential needs by employing open-source secure web-based tools such as RECap for housing and integrating data, statistical techniques appropriate for the complexity posed by the data including lag regression and generalized linear mixed effects models, and expertise in geographic information systems (GIS) programming. The Data & Statistics Core will ensure the success of the scientific goals for ASPiRE, which are strongly aligned with the public health goals of the NCI, by establishing shared data sources for the Research Projects, providing specific expertise on geospatial modeling, designing studies, implementing analyses, and providing principal interpretation for dissemination.